Cost and Non-Cost Barriers to Use of Novel AD Therapeutics among Older Hispanic or Latino Adults

Project Summary
The goal of this project is to assess the role of cost-associated barriers to new and future novel
AD/ADRD therapeutics in Hispanic or Latino older adults. Our work in the first (planning) phase
of the project will include semi-structured interviews with a cohort of Latino adults created as
part of the team’s ongoing work on diversity in clinical trials and an existing group of Latino
patients with AD/ADRD and their caregivers. The interviews will inform a subsequent
population-based survey to be fielded in the Understanding America Study, an online panel
study housed at the University of Southern California. Both the interviews and the survey will
elucidate cost and non-cost barriers to the use of new novel dementia therapeutics. The survey
will more fully and systematically capture the contribution of environmental, sociocultural,
behavioral, and biological factors to the demand for and use of these new medications for older
Hispanic adults and relative to non-Hispanic adults. The second, implementation stage of our
work will analyze existing Medicare claims and Encounter data to understand real world use
patterns. We will then use the team’s well-established dynamic microsimulation to estimate the
downstream impacts of use on cognitive and physical health, costs, and quality of life of older
Hispanic or Latino adults with dementia. The dynamic microsimulation model will be informed by
the work conducted in all other parts of the project both in terms of parameter inputs and
simulated scenarios.

Public health relevance
Project Narrative The goal of this project is to assess the role of cost-associated barriers to new and future novel AD/ADRD therapeutics in Hispanic or Latino people. To do this, we will engage both a cohort of Latino adults created as part of the team’s ongoing work on diversity in clinical trials and an existing group of Latino patients with AD/ADRD and their caregivers. Our work in the first (planning) phase of the project will include semi-structured interviews and a population-based survey to understand knowledge of and barriers to new novel AD therapeutics. The second stage of our work will analyze existing Medicare claims and Encounter data to understand actual use patterns. We will then use the team’s well-established dynamic microsimulation to estimate the downstream impacts of use on cognitive and physical health, costs, and quality of life of older Hispanic or Latino adults with dementia.